Effects of entinostat and neoantigen vaccination on bladder cancer

Project Summary/Abstract
Bladder cancer is a prevalent and deadly cancer, with over 80,000 new cases and 17,000 deaths annually in the
United States. Advanced bladder cancer has only a 15% 5-year survival rate. One of the most effective
treatments for advanced bladder cancer is immune checkpoint blockade (ICB), but only 20-30% of patients with
advanced bladder cancer respond and most responses are not enduring. A promising new treatment identified
by our group to improve bladder cancer ICB response is the selective class 1 histone deacetylase inhibitor
entinostat. In a mouse model, entinostat plus anti-PD-1 (αPD-1) ICB induced complete, enduring responses in
67% of mice. Entinostat decreased intratumoral M-MDSC and Treg populations, decreased tumor single-
nucleotide variant (SNV) neoantigen burden in vivo, increased expression of some SNV neoantigens in vitro,
and increased T cell specificity for these neoantigens in vivo. However, much of the mechanism behind response
to entinostat plus αPD-1 is unknown, particularly how entinostat decreases immunosuppressive populations and
affects expression of the neoantigen landscape. Understanding this mechanism is important to predict which
patients will respond and to potentially improve responses through antigen-directed therapy. We hypothesize
that entinostat-induced ICB response is driven by increased M-MDSC differentiation, decreased M-MDSC
migration, and increased expression of suppressed immunogenic neoantigens, augmenting response to
neoantigen vaccination. I will investigate two components driving response to entinostat plus αPD-1: M-MDSCs
and neoantigens. The training in computational and wet lab immunology, tumor biology and genetics, orthotopic
murine tumor models, and translational research with a clinical trial, will assist me in becoming an independently
funded physician-scientist leading a cancer immunology research lab and caring for bladder cancer patients.
In our M-MDSC-focused Aim 1, I will perform flow cytometry and transwell migration assays with M-MDSCs from
orthotopic bladder cancer model tumors to assess whether M-MDSC differentiation and migration are affected
by entinostat treatment. I will conduct immunofluorescence staining of human tumors from the LCCC1827
entinostat window trial (NCT03978624) to assess whether adding entinostat to ICB treatment decreases M-
MDSCs in humans. The Vincent Lab has developed LENS, a software platform to identify neoantigens from
multiple genomic sources. In our neoantigen expression-focused Aim 2, I will use LENS to identify all the
neoantigens in 3 murine bladder cancer lines developed by the Kim Lab, test T cell neoantigen specificity by
high-throughput ELISPOT, and use statistical modeling to predict neoantigens immunogenicity. I will also
validate whether entinostat-induced immunoediting occurs in human tumors from LCCC1827. In our neoantigen
vaccination-focused Aim 3, I will test whether neoantigen vaccination improves tumor response to entinostat
plus αPD-1. I will treat orthotopic tumors, measure their growth, and perform flow cytometry and single cell
RNAseq to measure non-exhausted neoantigen-specific CD8+ T cell abundance.

Public health relevance
Project Narrative Advanced bladder cancer has a poor prognosis, and only 20-30% of patients respond to immune checkpoint blockade. Response to the immune checkpoint inhibitor αPD-1 can be improved by adding the histone deacetylase inhibitor entinostat, but it is unknown how modulation of M-MDSCs and the neoantigen landscape can be leveraged to augment response. We hypothesize that entinostat-induced changes in M-MDSCs and neoantigen expression drive response to the combination of entinostat and αPD-1, and we seek to improve response through neoantigen vaccination.